Functional Competence in Alzheimer's Disease: A Novel Assessment Approach to Enhance Prediction of Risk in the Elderly

Project Summary/Abstract
By the year 2050, as many as 16 million individuals in the US will express symptoms of Alzheimer’s
disease (AD), a progressive neurodegenerative disorder marked by difficulties in memory, cognition and
instrumental activities of daily living (IADL). The 2015 White House Conference on Aging emphasized a critical
need for sensitive instruments to capture reduced functional capacity as a means to maximize independent
living and protect older adults from exploitation and abuse. Furthermore, the Food and Drug Administration
(FDA) recently recommended the measurement of subtle functional and cognitive changes during the
preclinical stages as a potential global outcome to evaluate the efficacy of treatment strategies and disease
modifying therapies in dementia research. However, despite the well-established importance of IADL detection,
there is a lack of research on when and how functional declines first become compromised and associated
brain changes along the disease spectrum. Prior research has failed to examine the emergence of subtle
functional deficits during early dementia stages such as among those with subjective cognitive decline (SCD)
and how such deficits advance in later stages, i.e., mild cognitive impairment (MCI), mild Alzheimer’s disease
(AD). Additionally, no formal studies have assessed sex differences in terms of the neural and cognitive basis
for functional abilities, considering the higher prevalence of IADL impairments in women.
Given these critical gaps in the literature, our project aims to track functional decline along the AD
continuum utilizing sensitive performance-based assessments, investigate sex differences and explore its
association with neuroimaging data. There is growing interest in utilizing performance-based assessments in
clinical trials as subtle errors in these tasks can potentially differentiate among preclinical, prodromal and more
advanced disease stages. In order for clinical trials to be successful, there is a strong need to incorporate
these sensitive instruments given their potential accuracy in capturing functional impairments during the
preclinical or prodromal disease stages. Thus, in the proposed study, among older adults who are cognitively
unimpaired and those with SCD, MCI, mild AD, we will: (1) elucidate new insights into IADL impairments during
early and advanced disease stages, (2) investigate cognitive and brain changes contributing to sex differences
in patterns of IADL impairments and (3) characterize the relationship between changes in functional brain
networks and IADL deficits. The achievement of our stated aims will result in an improved ability to detect and
identify emerging functional impairments in individuals along the AD continuum. Study findings also will
contribute to our long-term goals of developing safeguards to prevent functional deficits and potential
hazardous behaviors consequent to these impairments.

Public health relevance
Project Narrative By the year 2050, the number of older adults with Alzheimer’s disease (AD) is expected to rise to 16 million in the US, which highlights a critical need to identify sensitive changes associated with disease progression to aid with early detection and intervention strategies. This project aims to characterize the neuropsychological and neural basis as well as sex differences associated with functional competence across the disease continuum. Expected results will have implications for improving the safety and independence of at-risk individuals, since daily functional deficits are associated with increased vulnerability to exploitation and abuse.